Imaging the temperature sensing circuits in the spinal cord

Abstract: Spinal cord is the initial stage along the thermosensory pathway that integrates and processes temperature information from the peripheral thermosensory neurons. After tissue and nerve injury, there are significant changes at the level of the spinal cord and these maladaptive events often result in thermal allodynia (innocuous temperature perceived as painful) and hyperalgesia (normal noxious temperature elicit pain of greater intensity). The heterogeneity of the neurochemical organization of the dorsal spinal cord pose a major challenge for studying spinal cord circuitry and its changes in pain condition. Understanding the roles of distinct cell types hold the key to deciphering the neural circuits in the dorsal horn. Here, we propose to make use of a newly developed in vivo spinal cord imaging platform, a precisely controlled temperature stimulus system, and transgenic mouse lines to dissect the role of each cell type in processing temperature information in the spinal cord. In this proposal, we focus on spinal inhibitory interneurons as they are important for gating the transmission of pain information to the brain, and loss of inhibition has been proposed as a general mechanism for thermal hypersensitivity after tissue and nerve injury. In aim1, we will image thermosensory responses in different types of inhibitory interneurons, and examine the impact of silencing their activities on the sensory response in the rest of the circuitry. In aim2, we will perform the similar experiments in animal models of inflammatory pain to determine the changes in thermosensory responses of each type of inhibitory interneurons and their effect on other spinal neurons during inflammatory pain. The results from proposed work will not only provide basic knowledge on neurobiology of thermosensation, but also potentially generate insights useful for treating pain.

Public health relevance
Project Narrative Thermosensation is a fundamental and essential sense, which often undergoes maladaptive changes after tissue or nerve injury. Here we propose to combine genetic and pharmacogenetic tools with a novel in vivo two- photon imaging platform to study the encoding of temperature information in the spinal cord and how this coding scheme is altered by chronic pain. Results from this work could help identify new therapeutic targets for treating chronic pain.